Targeting TGF-beta activation in tumors

Targeting TGF-b activation in tumors Abstract Transforming growth factor-β (TGF-β) drives immune dysfunction in the tumor microenvironment by inducing regulatory T cells (Tregs) and inhibiting cytolytic CD8+ T cells and helper Th1 cells. TGF-b is ubiquitously expressed in mammals as isoforms TGF-b1, -b2, and -b3, but is maintained in an inactive form by non-covalent interaction with its propeptide, the latency associated domain of TGF-b (LAP). The integrin avb8 binds to the LAP of TGF-b1 and TGF-b3 and mediates their activation. Germline or conditional genetic deletion studies have revealed that integrin avb8-mediated activation of TGF-b is essential for the in vivo activation of TGF-b, and thus avb8 acts as a key modulator of TGF-b function. In general, integrins are adhesion molecules and mediate the attachment of cells to extracellular matrix proteins. Integrin avb8 recognizes an Arg-Gly-Asp (RGD) motif and interacts with fibronectin, vitronectin, and latent TGF-β isoforms, although it binds considerably more strongly to latent TGF-β than to other RGD-containing proteins (Ozawa, 2016). Despite the clear association of TGF-b signaling and T cell function, few therapies that target TGF-b have been successful, largely due to pan-inhibitor toxicity. To address this therapeutic challenge, we have identified a mouse monoclonal antibody (AMHA-11) that selectively blocks the interaction of the human integrin avb8 with its ligand, latent transforming growth factor-b (TGF-b). The AMHA-11 antibody is unique in that it selectively perturbs the avb8-mediated activation of TGF-b isoforms 1 and 3 and does not inhibit TGF-b2, which lacks an integrin-binding RGD motif. Additionally, because of redundant activities of other av integrins, cell adhesion is not perturbed by AMHA-11. This affords a higher degree of selectivity in perturbing only integrin avb8-mediated activation of TGF-b activation and not the residual cell adhesion properties, which may be undesirable to inhibit. In addition, global inactivation of TGF-b is likely to have undesirable side effects since TGF-b is an essential homeostatic epithelial and immune effector. In Phase 1 we will identify high-affinity humAbs that inhibit avb8-mediated activation of TGF-b, then rank-order them in vitro for their ability to inhibit TGF-b activation and to modulate T cell activity. We will also evaluate them in a small animal model as monotherapy and in combination with anti-PD-1. We are confident that a novel therapy will result from this more selective approach.

Public health relevance
Narrative Many cancer patients fail to respond to immunotherapeutics because of down-regulation of cytolytic T cell responses and exclusion from tumors. We have identified a new therapeutic that inhibits immunosuppression by regulatory T cells and increases intratumoral T cell infiltration. This novel cancer drug will enhance the body’s immune responses against tumor cells and increase the effectiveness of other immunotherapies.